Discourse Processing in Healthy Aging

DESCRIPTION (provided by applicant): The objectives of this research program are to determine whether age-related changes in discourse processes correspond to age-related changes in cognitive processes and to test hypotheses regarding discourse processing across the adult lifespan. Discourse processing is the most complex form of language processing and requires linguistic competence (e.g., comprehension) as well as linguistic performance (e.g., production). It has been suggested that age-related changes in language and cognition are related. However, a comprehensive and systematic description of age-related changes in discourse processing is lacking. The proposed research program will address this gap in aging research by evaluating the investigators'comprehensive discourse processing model that includes the multiple linguistic components and cognitive operations involved in discourse production. The significance of the proposed research program is that it charts change in discourse processes and cognitive processes across the adult lifespan in 10-year age cohorts (20s - 80s) and identifies how age-related changes in cognitive functions contribute to age-related changes in within-sentence and between-sentence processes. The specific aims of the proposed project are to: (1) determine how changes in memory and attention across the life span relate to competence and performance of narrative and procedural discourse, (2) document which aspect or aspects of discourse are most sensitive to aging in healthy adult cohorts, and (3) investigate age-related changes in comprehension of narratives across the adult lifespan. Structural equation modeling will be used to analyze the concurrent relationships between our latent variables of interest (cognition and linguistic processing) and manifest variables of interest (within and between sentence processes, linguistic competence and standardized measures of memory and attention). To address the second and third aims we have developed a series of subexperiments to answer our questions of interest;these data will be analyzed using classical ANOVAs as well as nonparametric (Wilcoxon) analyses. Results of this research will inform theories of discourse and cognitive aging as well as provide a normative database for clinical application to individuals with communication disorders associated with aging disorders and acquired neurogenic communication disorders.